Probing Alzheimer synaptopathy using genetically engineered human neurons derived from iPS cells

In the previous funding period of this R01, that we are seeking to renew, we have made the remarkable
observation that the Swedish mutation in the Alzheimer Precursor Protein (APP), which causes familial
Alzheimer's disease (AD), induces an increase in synapse formation in human iPS cell-derived neurons.
Importantly, we established that this effect is caused by Amyloid beta (Ab) and not any other APP cleavage
product altered due to the more efficient b-secretase cleavage. This finding was surprising since elevated Ab is
considered one of the key drivers of neurodegeneration in AD. In the first aim we propose to elucidate the
mechanism of how Ab induces synapses. We will test whether the synaptogenic effect is induced by Ab peptides
more or less prone to aggregation and whether decreasing aggregated Ab affects synapse formation. After
establishing the dynamics of Ab-induced synaptogenesis, we will map out the neuronal signaling pathways that
lead to synapse formation in direct or indirect response to Ab. In our second aim, we will establish whether the
Ab acts directly on neurons or indirectly via astrocytes or microglia. The latter hypothesis may be attractive since
astrocytes promote synapse formation physiologically. Using a newly developed all-human iPS cell-derived
neuron, astrocyte, and microglia tri-culture system we will further evaluate whether Ab may be presented
differently in a human neuro-glial cell context as opposed to human neurons grown on mouse primary glia which
is the context we have studied synaptic biology so far. Human neural organoids consisting of defined proportions
of neurons, astrocytes, and microglia will further allow to address the question whether three-dimensional tissue
and cell-produced extracellular matrix affects the synaptogenic effects of Ab. To investigate how Ab affects the
three different cell types, we will perform single cell and nuclear transcriptional profiling of two-dimensional tri-
cultures and organoids from APPSwe and control cells. In our third and final aim, we seek to further investigate
the role of Tau pathology and ApoE on neuronal function. In the previous funding period we identified an ApoE-
induced synapse formation by activation of ApoE receptors and downstream kinases DLK, MKK7, and ERK1
and phosphorylation of the transcription factor CREB. Intriguingly, ApoE4 stimulated this pathway and induced
synapses better than ApoE3, and ApoE3 better than ApoE2. In addition, ApoE variants have been involved in
many cell biological aspects. Tau aggregation and its prion-like spreading is another hallmark of AD pathology.
We will apply recent breakthrough technologies to model Tau spreading in human neuronal cultures. Other than
focusing on the mechanisms of Tau spreading, we here propose to assess its effect on synaptic function,
consistent with the overall theme of this project. Here we propose to utilize our improved tri-culture and organoid
models which allow more complex cell-cell interactions and our successful conditional gene editing approach
that allows the derivation of truly isogenic controls in order to assess DLK/MKK7/ERK-dependent and
independent effects of ApoE variants and perturbations on neuronal function.

Public health relevance
We have made the unexpected finding that beta amyloid, which is largely considered to cause neurodegeneration in Alzheimer's disease, in fact promotes neuronal function by improving their communication. In this proposal to renew our current grant, we propose to investigate the molecular and cellular mechanisms of how beta amyloid affects neurons in this way.